Onco-immunologic factors contributing to OPSCC among people living with HIV

Oropharyngeal cancer (OPC) is a type of head and neck cancer and ~70% cases of OPC are associated with
high-risk (hr) human papillomaviruses (HPV) infection. OPC cancers are increasing in prevalence especially in
persons living with HIV (PWH) and this group also has higher rates on HPV associated OPC. Reasons for these
findings are not well understood. While antiretroviral treatment (ART) does diminish HIV replication and immune
activation, in a large majority of PWH it is generally started in chronic infection, when HIV reservoirs have already
been established and uncontrolled HIV replication has resulted in significant immune dysfunction. Based on our
preliminary data and what is known in the literature, we hypothesize that ongoing HIV replication and the resultant
production of its proteins upregulates oncogenic HPV proteins (E6 and E7) thereby enhancing the probability of
OPC development. HIV replication also results in exhaustion of CD8 T cells which is further exacerbated by
increased HPV replication making HPV-specific CD8 T cells especially prone to overstimulation and exhaustion.
These dysfunctional CD8 T cells thus make it even more likely for OPC to occur in PWH. Furthermore, both HIV
protein production and immune activation continue after potent ART is started. As such, production of HIV
proteins from previously latently infected CD4 T cells continues to drive HPV oncogenic protein production as
well as CD8 T cell exhaustion and OPC continues to occur at higher rates in these PWH. Solidifying this overall
hypothesis as proposed in our 3 aims would provide comprehensive insights into the mechanisms of OPC in
PWH leading to improved prevention and therapies. Our overall study hypothesis is that chronic inflammation
despite ART in PWH favors both persistence and proliferation of hrHPV16 infected oropharyngeal
epithelial cells and contributes to impaired anti-HPV specific T cell immunity leading to initiation of OPC.
We will test this hypothesis in the following three aims: In aim 1, we will determine the HPV types present in
OPC from PWH and how T cell mediated anti-tumor immunity is impaired. We will examine whether multiple
HPV subtypes persist. In addition, we will determine whether tumor and CD8 are spatially distant and whether
the intra-tumoral CD8 are exhausted. Our aim 2 will determine how an HIV infection influences HPV
infection, its gene expression and DNA replication to facilitate oncogenic transformation of
oropharyngeal epithelial cells. Using 3D based models, we will show that HIV infection via its specific proteins
(Tat and/or envelope gp120) modulates HPV pathogenesis by interfering at one or more steps in its life cycle.
In aim 3, we will determine the mechanisms of HPV specific CD8 T cell dysfunction in PWH with OPC and
whether tumor specific immunity can be restored. Our successfully completed studies will show how chronic,
albeit low grade inflammation in PWH on ART is beneficial to the initiation of HPV associated OPC via increased
susceptibility of epithelial cells to HPV infection, increased oncogene expression which when coupled with an
inability of CD8 T cells to kill HPV infected cells tips the balance of an HPV infected cells towards OPC initiation.

Public health relevance
PROJECT NARRATIVE Oropharyngeal cancer (OPC) is commonly associated with Human Papilloma Virus (HPV) infection. The goal of this work is to understand how oropharyngeal cancer (OPC) is initiated when an individual is already infected with another chronic virus like HIV. These studies will identify early virus induced changes in the host that lead to OPC.